Harnessing interpersonal connections for improved patient-oriented research for people who inject drugs (PWID)

PROJECT SUMMARY/ABSTRACT
Dr. Meghan D. Morris, PhD, MPH, is an Associate Professor of Epidemiology at the University of California,
San Francisco, with expertise in infectious disease and social epidemiology. Her research program focuses on
patient-oriented research with a primary emphasis on addressing health inequities among people who inject
drugs (PWID). Her competencies include advanced skills in qualitative, quantitative, dyadic research, and
community-engaged research methods. She has a long track record of mentoring scholars across various
academic levels. The K24 award provides Dr. Morris with protected time and essential resources to establish a
mentorship program and cultivate a new cohort of health equity researchers who will apply dyadic research
methods through community-engaged research to enhance the health and well-being of PWID.
Dr. Morris's K24 research strategy builds on Dr. Morris’ existing NIH-funded study (R01DA053325) of the
Partner Navigation Intervention, a dyadic intervention designed to enhance HCV treatment initiation among
PWID by leveraging support within injecting partnerships. Project 1 will examine how racialized discrimination
affects treatment initiation and partner support dynamics, generating findings to inform future adaptations using
anti-racism principles. Project 2 will pilot an adapted Partner Navigation Intervention session upon HCV
treatment completion to promote continued healthcare engagement for comorbid conditions, addressing a
critical gap in post-treatment care for PWID. The interdisciplinary mentoring team includes expertise in patient
outcomes research, culturally responsive intervention adaptation, dyadic and quantitative research methods,
and anti-racism frameworks.
The K24 award will enable Dr. Morris to formalize and expand upon the team-mentoring program she has
developed and piloted over the past 5 years informed by frameworks from the National Center for Faculty
Development and Diversity (NCFDD) and the Signaling Affirmation for Equity (SAFE) model, utilizing a team-
mentoring approach bringing together academic and community members with lived experience of substance
use as near-peers. As dyadic research among substance-using populations is an emerging area of study, a
national approach to mentorship to promote innovation in patient-centered research is critical.

Public health relevance
PROJECT NARRATIVE The public health relevance of this application is that there is a critical shortage of patient-oriented researchers skilled in community-engaged research with people who use drugs. Dr. Morris plans to implement a team- centered mentoring approach to cultivate a diverse group of health equity scholars. They will receive training in utilizing dyadic research methods to effectively leverage social connections for the purpose of enhancing the health of people who use drugs.